Neural Bases of Disgust Conditioning in Anorexia Nervosa

PROJECT SUMMARY/ABSTRACT
This K23 application aims to support Dr. Lisa Anderson to achieve her overarching goal of establishing an
independent, patient-oriented research career that will (a) elucidate biological and psychological mechanisms
associated with risk and maintenance of eating disorders, and (b) use this information to develop and optimize
precise, efficacious treatments for eating disorders. The proposed application will strengthen Dr. Anderson’s
abilities to meet her career goals by providing advanced training designed to: (a) develop expertise in theory
and assessment of disgust conditioning mechanisms involved in transdiagnostic models psychopathology
characterized by avoidance behaviors, and to translate this knowledge to research for eating disorders; (b)
gain knowledge and skills in neuroimaging methods necessary to conduct independent research investigating
the neural substrates of disordered eating; and (c) obtain advanced training in analysis of neuroimaging (fMRI)
data required to independently examine maintenance mechanisms underlying eating disorders across various
units of measurement (i.e., psychological-, behavioral-, physiological-, and neurobiological-level variables). Dr.
Anderson has assembled a team of experts who will provide training to accomplish the proposed training goals
and scientific aims. The core mentorship team consists of Dr. Scott Crow (training in translational eating
disorders research), Dr. Kathryn Cullen (neuroimaging training), Dr. Mark Fiecas (biostatistics), Dr. Shmuel
Lissek (cross-diagnostic models of disgust learning), and Dr. Thomas Hildebrandt (translation of disgust
learning models to eating disorders, computational modeling of aversive reinforcement learning in anorexia
nervosa [AN]). Dr. Kelvin Lim will consult on neuroimaging study design and R01 application preparations. Dr.
Carol Peterson will consult on emotion regulation models and emotion-based mechanisms research for eating
disorders. Dr. Josh Cisler will consult on disgust-based task design and computational models of aversive
reinforcement learning. As part of her training, Dr. Anderson will complete a two-part study. Study 1a will
compare patterns in neural activation during a food-specific disgust generalization and extinction task between
individuals with AN and non-eating-disorder comparison participants to establish the extent to which the neural
substrates of food-specific disgust generalization and extinction specifically relate to food avoidance and
restrictive eating severity in AN. In a longitudinal arm, Study 1b will determine the extent to which neural
activation patterns associated with disgust generalization and extinction predict later AN maintenance. Overall,
in addition to supporting Dr. Anderson’s training goals, this project will meet a critical need by identifying
disgust conditioning mechanisms that may underlie food avoidance symptom severity and disorder
maintenance in AN. This knowledge will ultimately inform the development of novel biological treatments (e.g.,
psychopharmacology, neuromodulation) and optimization of psychological interventions (e.g., reinforcement-
based psychotherapies) that promote long-term recovery from this persistent psychiatric disorder.

Public health relevance
PROJECT NARRATIVE Anorexia nervosa (AN) is a serious psychiatric disorder associated with significant impairment and increased risk of death. This study will establish the extent to which neural bases of disgust generalization and extinction processes contribute to AN symptom expression, as well as determine the extent to which these patterns of neural activity predict AN symptom maintenance. By identifying the neurobiological processes underlying core symptom expression and maintenance in this population, the proposed research represents a critical next step needed to develop more precise models of AN and has potential for substantial impact on the development of innovative and effective neurobiologically-based treatments for this severe and persistent disorder.